Molecular and Cellular Analytical Core

PROJECT SUMMARY – MOLECULAR AND CELLULAR ANALYTICAL CORE
The overall objective of the Molecular and Cellular Analytical (MCA) core is to support investigation of human and non-human metabolism from a cellular and molecular perspective. The MCA Core will provide expertise, facilities, and equipment for 1) mass spectrometry (MS) applications in lipidomics and isotope enrichment; 2) genomic and transcriptomics; and 3) cellular respiration and mitochondrial function. The leadership team (Drs. Bryan Bergman, Kartik Shankar, Matthew Jackman, and Karin Zemski Berry) bring a wealth of expertise in nutrition, obesity, and metabolic research. The lipidomic and mass spectrometry component provides quantitative lipidomic analysis on plasma, cells, and tissues, as well as help with data interpretation, in addition to determination of isotope enrichment and concentration of metabolites in blood and breath used in isotope tracer studies. The genomics and transcriptomics component has established a nutrition- and obesity- informed conduit for NORC Members to access and apply Next Generation Sequencing to their research, which includes nucleic acid extraction, advanced computational processing, and pathway, network, disease, and regulator discovery tools for RNAseq and related sequencing experiments. The cellular/mitochondrial function component provides expertise and access to core equipment that can measure respiration and molecular aspects of cells and isolated mitochondria. Over the past 5 years, the MCA Core established an excellent track record of productivity and a substantive institutional investment to support nutrition and obesity research. The MCA Core now plans to leverage a renewed institutional investment to sustain its valuable operations, adapt to the evolving needs of its research base, and facilitate the advancement of science of nutrition and obesity through its efforts in the Rocky Mountain region.